Two-way Magnetic Resonance Tuning Nanoprobe Enhanced Subtraction Imaging for Precision Diagnosis of Brain Metastasis

Title: Two-way Magnetic Resonance Tuning Nanoprobe Enhanced Subtraction Imaging for Precision
Diagnosis of Brain Metastasis
Project Summary/Abstract
Metastasis from systemic cancers to the brain is a leading cause of cancer mortality. The current diagnostic
method is sensitive only to larger tumors when therapeutic options are limited. Visualizing early brain metastases
by non-invasive imaging approaches with high sensitivity and spatial resolution followed by timely treatment is
crucially important to reduce their high mortality rate. While effective interventions (e.g., surgery, radiation,
targeted therapy, and immunotherapy) strongly depend on our ability to detect brain metastases at an early
stage, imaging small brain metastases hidden in a large population of normal cells presents a unique challenge.
It is essential to design novel imaging approaches to detect small brain metastases with the highest possible
tumor-to-normal tissue ratios (TNRs). The goal of this application is to develop a new molecular nanoprobe with
activatable magnetic resonance contrast integrated with a new computational subtraction approach to improve
the TNR of imaging for small brain metastases. We recently developed a new two-way magnetic resonance
tuning (TMRET) nanoprobe with dually activatable T1&T2 magnetic resonance signals coupled with dual-contrast
enhanced subtraction imaging (DESI) to dramatically enhance contrast in targeted tissues and suppress the
background signal from normal tissue. This integrated platform could sensitively detect very small tumors in the
brain by magnetic resonance imaging (MRI) in patient-derived xenograft (PDX) models with a TNR >10. We also
developed a Sequential Targeting In CrosslinKing (STICK) nano-delivery strategy to “stick in” central nervous
system (CNS) tumors and metastases, which will be applied to our TMRET nanoplatform to enhance its specific
delivery to brain metastases. In this project, we will develop novel blood-brain barrier (BBB)-traversing and deep
tumor-penetrating TMRET (bt-TMRET) nanoprobes with superior TNR for sensitive and specific detection of
brain metastases. The STICK strategy will be used to improve the CNS pharmacokinetics (PK) of TMRET
nanoprobes by pHe-cleavable crosslinkers to maximize the time window for transcytosis through the BBB. Our
STICK strategy will further enhance the efficiency of BBB traversal by manipulation of glucose transporter 1
(GLUT1) on the BBB by optimization of the polyvalent interaction of nanoprobes with GLUT1 via fine-tuning the
surface targeting moieties. The STICK strategy optimizes the pH-responsive size transformation for improved
tumor tissue penetration and sialic acid-targeting selectivity for enhanced tumor cell specificity. The MRI signal
can be turned ON specifically at the brain metastases after BBB traversal and tumor penetration via size
transformation in acidic tumor microenvironment. Our hypothesis is that the proposed nanoprobes can improve
the TNR for MRI detection of small brain metastases through a synergized strategy of background suppression,
signal amplification via deep penetration and specific targeting in brain metastases and activation at tumor sites,
and DESI technology will further enhance the TNR. This new imaging platform is expected to improve cancer
detection in the clinic and serve as a great tool for biomarker detection in preclinical research.

Public health relevance
Project Narrative Accurate diagnosis and assessment of brain metastases in patients with systemic cancers has important implications for patient prognosis and treatment strategy. The proposed two-way magnetic resonance tuning nanoprobes and complementary subtraction imaging technology with ultra-high tumor-to-normal tissue ratios will provide neuroradiology practice with a highly capable, accurate and consistent approach for detecting and evaluating early brain metastases. This new imaging technology has great potential to be translated in clinic to improve survival and reduce the mortality rate in patients with brain metastases in the near future.